The Emory Training Program in Lung Health

PROJECT SUMMARY/ABSTRACT
The Emory Training Program in Lung Health is in its 4th year, having begun on August 1st, 2013 with the goal of
training highly collaborative MD, MD/PhD and PhD post-doctoral translational investigators who can transform
our ability to promote lung health in our society. In the current first 5-year funding period the Program supports
four post-doctoral training slots and two short-term summer fellowships per year for African-American medical
students from the Morehouse School of Medicine. The Program is directed by Lou Ann Brown, PhD and David
Guidot, MD; for the next funding period (Years 6-10) they are joined by Mike Hart, MD. These co-directors are
long-time collaborators, both in their research programs and in their leadership of T32-supported post-doctoral
training at Emory University for the past fifteen years. They have enlisted a multidisciplinary faculty of mentors
from the School of Medicine and the Rollins School of Public Health at Emory University. The Program and its
faculty mentors encompass nearly every facet of pulmonary biology, but clear areas of excellence include
translational research in Cystic Fibrosis, Pulmonary Vascular Disease, Pulmonary Immunology, Redox
Biology, Metabolomics, Airway Epithelial Biology, Pulmonary Innate Defense and Infections, and HIV- and
alcohol-mediated lung disease. Post-doctoral MD and MD/PhD fellows will be recruited from the multiple
outstanding fellowship training programs in the Departments of Pediatrics and Medicine from which the faculty
mentors are drawn. Post-doctoral PhD fellows will be recruited from the national pool of qualified candidates as
well as from the local pool of doctoral students completing their pre-doctoral education in the Graduate Division
of Biological and Biomedical Sciences within the Laney Graduate School at Emory University. The two short-
term summer research students will be recruited from the Morehouse School of Medicine where the Program
Directors have an established relationship with the Dean of Student Affairs and a substantial training history
with their top students over the past decade. Trainees work in collaborative research activities and have
access to a wide range of institutional resources including the Masters of Science in Clinical Research
Program that has proven to be an invaluable experience for a large number of our post-doctoral fellows and
junior faculty over the past fifteen years. Our Training Program has filled all of its positions and in light of the
diverse and large pools of outstanding candidates coupled with the capacity of the faculty mentors we are
requesting a graduated increase in the number of post-doctoral positions over Years 6-8 such that we can
reach our optimal size of eight positions going forward. Lung health is an enormous challenge in our society,
with lung diseases accounting for an ever increasing global burden in morbidity and mortality. There are
compelling reasons to train investigators from diverse backgrounds and disciplines and provide them with the
collaborative skills to meet this challenge and improve lung health across the lifespan.

Public health relevance
PROJECT NARRATIVE This is the first competing renewal for Years 6-10 of The Emory Training Program in Lung Health, which is designed to train the next generation of translational investigators with the collaborative skills necessary to synthesize laboratory-based research and clinical discoveries into therapeutic strategies that can enhance lung health. The Program emphasizes multidisciplinary mentoring teams and collaborative training of MD, MD/PhD and PhD postdoctoral fellows as well as African-American medical students from the Morehouse School of Medicine who learn to engage in translational team science. The research environment and resources at Emory University are fertile and include the Masters of Science in Clinical Research Program, The Georgia Clinical & Translational Science Alliance, and the Office of Postdoctoral Education, all of which are leveraged by this training program to develop collaborative investigators dedicated to the missions of the National Heart, Lung and Blood Institute.